Biomarkers of Developmental Language Disorder and Their Relationship to Language Impairment

Project Summary/Abstract
The goal of the proposed fellowship is to explore the relationship between brain function and language
impairment in children with Developmental Language Disorder (DLD) by investigating two measures of
brain function, cerebral blood flow (CBF) and functional connectivity. DLD is a pervasive developmental disorder
with childhood onset that can persist into adulthood and affect psychosocial relationships and socioeconomic
outcomes, yet little is understood about the brain correlates of DLD. It is believed that some combination of
genetic and environmental factors influences brain development in this population, but the relatively few
neuroimaging studies have revealed inconsistencies regarding the ways in which these factors contribute to
language impairment. We argue that functional brain differences may underlie these discrepancies. Therefore,
the research proposed here addresses the critical need to better characterize the underlying neurobiological
mechanisms that contribute to language impairment in children with DLD. In alignment with the NIDCD’s mission,
this project seeks to identify biomarkers of DLD that can inform development of targeted interventions aimed
at improving the functional outcomes for people with DLD. This will be achieved by comparing resting state CBF
patterns in children with DLD (ages 9-11) to typically developing (TD) age-matched peers (Aim 1). Currently
there are only a handful of studies that have investigated CBF in DLD, but these studies had poorly matched
participants and used invasive and spatially limited methods. To our knowledge, this project will be the first to
utilize arterial spin labeling, a non-invasive method for capturing whole brain CBF patterns. In addition, we will
compare intrinsic functional connectivity (iFC) patterns within the language network in these two groups using
functional connectivity MRI (Aim 2). To date, there are no studies that have investigated iFC in DLD, yet this
method has revealed relationships between altered functional architecture and behavior in other neurodiverse
populations, making it reasonable to suspect that children with DLD may also demonstrate a similar relationship.
Finally, we will compare the relationship between the two measures from aims 1 and 2 to scores on linguistic
and non-linguistic assessments to determine if they are related to language behavior (Aim 3). We will also
investigate whether there is a correlation between CBF and functional connectivity patterns, as research has
revealed that some neurodiverse populations demonstrate deviations in these patterns when compared to
neurotypical populations. The proposed research will provide a novel approach to understanding the connection
between underlying brain function and language behavior in DLD. The applicant’s experienced training team and
available resources through two highly productive research institutions and mentoring labs, make them well-
suited for completing the proposed research and contributing important findings to a critical and understudied
area of research.

Public health relevance
Projective Narrative Developmental Language Disorder (DLD) is a pervasive language disorder that can affect both comprehension and production of spoken, written and signed language, yet little is understood about the underlying neurological basis for DLD. The goal of this proposal is to explore the relationship between language impairment and two measures of brain function, cerebral blood flow and functional connectivity, in children with DLD. By exploring underlying measures of brain function in DLD, we can begin to identify biomarkers of language impairment that may lay the groundwork for aiding in the identification and treatment of the disorder.